Seattle Quant: A Resource for the Skyline Software Ecosystem

Development on Skyline started in 2008 to fill a critical need for a software tool to enable targeted proteomics
experiments. The development of Skyline grew into an entire ecosystem of tools and has since expanded
beyond targeted proteomics. The Skyline software ecosystem is one of the most widely used software
platforms in all of mass spectrometry. The current software and its thriving community create exciting new
opportunities for quantitative mass spectrometry. As of June 2020, Skyline has been installed >110,000 times,
has over 14,000 registered users on its website (http://skyline.ms) and is booted up >9,000 times per week
(exceeding 17,500 bootups in a single vveek). The Skyline project has grown beyond the bounds of a single
tool. There are now 16 Skyline external tools that rely on a formalized framework in Skyline, with more in
development. Some of these tools have been installed >10,000 times. We have also created the Panorama
Knowledgebase (http://panoramavveb.org) and Panorama Public, a platform where Skyline users can organize,
share, and disseminate processed quantitative proteomics data. Furthermore, our lab is now the primary
contributor to Chorus (http://chorusproject.org), a unique mass spectrometry file sharing resource. In this
grant, we propose creating a resource that will enable the continued development and maintenance of these
community tools and their dissemination within the community. These tools support >14,000 registered users
in their basic science, pre-clinical, and translational research. Specifically, our proposal has four aims. 1)
Expand our test infrastructure to improve the robustness, stress test the software, confirm compatibility across
computer systems, and track performance over time. 2) Improve support for both proteomics and nonproteomics
workflows. 3) Improve the collection, sharing, annotation and dissemination of mass spectrometry
data and Skyline documents. 4) Provide continued support and training for the Skyline ecosystem.

Public health relevance
Mass spectrometry has been a fundamental technology for the analysis of proteins in health and disease. Quantitative mass spectrometry measurements offer a promising alternative to immunological based assays that are the standard for quantitative protein measurements in clinical and basic research laboratories. Critical to these experiments is our software, Skyline and the associated ecosystem of tools, which have been developed to handle the generation of instrument methods and the subsequent analysis of the resulting data.